COMPARISON OF CREON 20 AND PLACEBO IN TREATMENT OF STEATORRHEA IN CF PATIENTS

The purpose of this study is to determine the safety and efficacy of Creon 20 in controlling the symptoms of malabsorption in pancreatic insufficient patients with cystic fibrosis. This is a double blind, placebo-controlled trial.